Ion Channels and Excitability in the Peripheral Vestibular System

Project Summary
Approximately 8 million adults in the US suffer from balance impairment due to damage to the peripheral
vestibular system, but effective treatments for balance dysfunction are lacking. Vestibular hair cells within
vestibular canal and otolith organs convert motion into receptor potentials and sensory information is relayed to
the brain by action potentials (APs) in vestibular afferent nerves. Afferents in central zones (CZ) of vestibular
neuroepithelia exhibit different responses to vestibular stimuli than afferents in peripheral zones (PZ). The
nature of the neural code conveying vestibular information in distinct afferent types is poorly understood. There
are 3 types of vestibular afferents: calyx-only afferents innervate one or more type I hair cells, bouton dendrites
innervate type II hair cells and dimorphic afferents contact both hair cell types. Our goal is to elucidate distinct
AP firing mechanisms in afferents with calyx terminals to better understand vestibular coding. Calyx-only
afferents are present solely in CZ and have irregular firing patterns, whereas dimorphic afferents exist in both
CZ and PZ and have regular firing patterns. To achieve our goal we will refine novel preparations of vestibular
cristae and utricles, developed by our laboratory, as tools to study calyx-bearing afferents in CZ and PZ of
gerbil neuroepithelia. Electrophysiological, hair bundle stimulation, immunohistochemical and pharmacological
approaches will allow characterization of ion channels in afferent fibers in developing and mature epithelia. In
Aim 1 we will determine the contributions of K+ channels and hyperpolarization-activated cyclic nucleotide-
gated channels to AP firing in CZ and PZ afferents. Aim 2 will test the hypotheses that Nav1.6 channels with
transient and resurgent characterisitics contribute uniquely to AP firing in mature PZ dimorphs. In Aim 3 we will
incorporate ion channel data from Aims 1 and 2 into a novel, custom-written three dimensional mathematical
model of the calyx to provide insight into our zonally-driven experimental findings. To determine how channel
localization directly impacts AP firing, identified channel types will be strategically placed on the inner and outer
faces of the calyx terminal and associated axon and channel density varied. Our results will clarify how sensory
information is conveyed and how zonal encoding is generated within segregated vestibular afferents. Our data
will inform development of vestibular neurotherapeutics targeting specific groups of ion channels in afferent
nerves. Existing vestibular prosthetic implants attempt to restore normal vestibular function by direct electrical
stimulation of vestibular afferents. A clearer understanding of AP generation and propagation within vestibular
afferent sub-types is needed to inform appropriate electrical stimulation parameters. Results from this work
could provide important new information on vestibular afferent coding and inform development of
pharmaceutical and electrical strategies to combat vestibular dysfunction.

Public health relevance
Project Narrative The proposed studies will elucidate action potential firing mechanisms in different types of afferent neurons in the peripheral vestibular system using a combination of electrophysiological, immunohistochemical and mathematical modeling approaches. Understanding how vestibular information is relayed to the brain has important implications for developing new therapies involving pharmacological approaches and design of implants for patients with vestibular dysfunction.